Mechanisms Regulating Neuronal Specific Proteasomes in Neurodegeneration

Proteasomes are essential for protein homeostasis and proper neuronal function throughout life. This new
application focuses on studying a newly discovered neuronal specific abundant proteasome complex and its
link to neuronal function in health and aging related neurodegenerative disease. Based on extensive original
findings, our central hypothesis is that neuronal activity promotes the degradation of newly synthesized
proteins through a transmembrane-like proteasome complex in order to rapidly generate biologically
meaningful peptides that are critical for normal nervous system function and appear protective against
neurodegenerative processes. The rationale for the proposed research is that nothing is known about this new
form of protein homeostasis and further understanding is critical in providing vital insight into neuronal
functions mediated by protein degradation. Given the critical importance of protein degradation to human
health, the long-range objective of the proposed research is to understand the regulation and function of this
degradation program and to apply this knowledge to the detection and eventual treatment of cognitive
disorders. Specifically: Aim 1. To identify and study molecular components required for NMP complex
assembly and function, to test our hypothesis that a glycoprotein mediates transmembrane like association
of the proteasome in the neuronal plasma membrane, which is critical for promoting NMP mediated peptide
release and is in part controlled by the disease causing β–amyloid protein; Aim 2. To identify and study
specific NMP peptide-receptor interactions relevant to neuronal signaling, to test our hypothesis that
distinct amino acid sequences within NMP substrates are critical for NMP dependent degradation into unique
peptides that activate NMDAR dependent neuronal signaling and that this interferes with Aβ induced
pathologies; Aim 3. To investigate NMP relevance to neuronal physiology in healthy and diseased
brains, to test our hypothesis that inhibition of NMP function affects neuronal physiology and is relevant to
nervous system aging and neurodegenerative decline.

Public health relevance
The proposed studies are designed to understand at the biochemical, molecular, cellular and physiological level the formation, signaling and function of a novel neuronal transmembrane-like proteasome complex and its resulting proteasomal signaling peptides. The successful completion of this work will provide vital insights into this new modality of neuronal protein homeostasis as it pertains to healthy and Alzheimer's relevant neuronal functions. Given the high prevalence between abnormalities associated with the proteasome and neurodegenerative disorders, any advancement in our understanding of the molecular mechanisms mediating neuronal specific protein degradation mechanisms and brain function promises to improve pharmacological approaches for the treatment of individuals with age related brain impairment.